USC Facebase IV Craniofacial Development and Dysmorpholoy Data Management and Integration Hub (FaceBase IV))

PROJECT ABSTRACT
Dental, Oral and Craniofacial health (DOC) plays a significant factor in the overall well-being of
the population. About half of all birth defects are associated with craniofacial malformations.
Many other genetic conditions manifest themselves via phenotypes in the face and skull and are
associated with communication disorders, neurological development and other factors.
Furthermore, oral health plays a significant role in overall human health.
Driven by the importance of DOC research to overall human health, the National Institute of
Dental and Craniofacial Research (NIDCR) established the FaceBase Consortium in 2009 to
advance research relevant to the NIDCR mission by creating comprehensive datasets of
craniofacial development and dysmorphologies in order to disseminate these datasets to the
wider craniofacial research community and support reuse of data for new research projects and
collaborations. SInce its creation, FaceBase has become a central data repository resource
funded for diverse dental and craniofacial researchers.
We propose to build on the success of FaceBase to date to 1) expand our inclusive community
outreach, training, and education resources by fostering an active and diverse community of
users across the translational spectrum of Dental, Oral and Craniofacial (DOC) and related
disciplines trained in use of FaceBase, 2) enhance FaceBase services to efficiently serve a
growing community ranging from single investigators to multi-consortia, and empower scientists
across the translational spectrum of DOC research and other relevant health studies to advice
their research using FAIR, TRUSTworthy, scientifically robust, data-driven, and AI/ML/DL-ready
resources, and 3) build on our robust and agile project management structure to meet the new
requirements of the extended use cases and community envisioned by this proposal.

Public health relevance
PROJECT NARRATIVE The major goal of the FaceBase data resource is to advance the impact of research into Dental, Oral and Craniofacial health and disease on improving human health. We will acomplish this by expanding the the scope and scale of the existing FaceBase data repository resource to include research across all of DOC research and across the translational spectrum, from basic research to clinical applications.